Modernization of Cage Washing Equipment for The Natural Science Center's Vivarium to Jointly Support Multi-Disciplinary Research and Georgia State University Sustainability Initiatives

Project Summary:
The aim of this request is to modernize the cage wash facility within a biomedical animal
research facility that supports NIH funded research and GSU’s Transgenic and Gene Targeting
Core. This cage wash facility supports an attached animal facility, along with an upcoming
satellite ABSL3 animal facility, that averages around 1,200 cages at a given time. The cage
washer located within this facility is outdate and struggles to maintain the pace needed for this
census due to building and utility limitations. Through replacing this machine, with a more utility
efficient machine, the cage wash facility will be able to quadruple the throughput. This will allow
the staff to work more efficiently in order to support the research needs and to ensure all items
are sanitized and decontaminated properly in a timely fashion. Cycle times are predicted to be
reduced from the current 35 minutes per load to 8 minutes per load. Additionally, this new
machine will decrease our utility consumption immensely, which will support GSU’s
sustainability initiatives to decrease our environmental impact across campus. Water usage will
decrease over 90% with the new washer going from 150 gallons per cycle to a mere 13 gallons
per cycle. This grant will also fund a bedding dispenser to help the cage wash staff ensure all
cages are made in a uniform fashion, while also providing them with allergen and ergonomic
injury protection. Bedding levels in individual ventilated cages can affect air conditions within the
cage. Having an automated dispenser will ensure that cages are bedded uniformly and have
similar conditions at all times across a study. Both of these listed items will contribute to GSU’s
mission to provide a controlled and clean environment that supports meaningful, translatable
and reproducible research.

Public health relevance
Project Narrative: Research in the Natural Science Center’s main vivarium is concentrated in the areas of cancer and metabolic disease (i.e., diabetes, obesity, cardiovascular diseases, fatty liver disease, etc.). The cage wash facility of a vivarium is essential in ensuring the prevention of cross contamination of sensitive animal models and that housing conditions are prepared in a uniform fashion. By modernizing this cage wash facility to today’s standards, we would be ensuring that we are providing a clean, controlled, and consistent environment to support meaningful animal research.